Mechanistic Contribution of Internal Circadian Misalignment to the Cardiometabolic Risk of Sleep Loss

PROJECT SUMMARY/ABSTRACT
Over one in three Americans regularly sleep less than the recommended 7 hours per night and thus obtain
insufficient sleep. Compared to adults who maintain adequate sleep durations, adults who maintain
insufficient sleep are at higher risk of developing obesity and type 2 diabetes (T2D). Furthermore,
experimentally imposed sleep restriction in otherwise healthy adults can impair insulin sensitivity to levels
commonly observed in people with pre-diabetes or in aging. Given the strength of this rigorous body of
evidence, clinical guidelines recommend “healthy sleep” to help prevent and manage cardiometabolic disease.
However, effective interventions to increase sleep duration and mitigate the adverse cardiometabolic risk of
insufficient sleep are limited. Moreover, achieving adequate sleep may be impractical for many people like
medical and military personnel, emergency responders, shift workers, and students. Thus, interventions that
mitigate the adverse cardiometabolic risk of insufficient sleep, even when sleep loss is unavoidable, could have
significant public health benefits. A key barrier limiting the development of such interventions is that the
precise physiological mechanisms mediating the adverse cardiometabolic risk of insufficient sleep remain
unclear. One understudied and potentially modifiable mechanism contributing to the adverse cardiometabolic
risk of insufficient sleep is circadian misalignment. Specifically, our preliminary data strongly suggest late
night light exposure and food intake during sleep loss cause an internal misalignment of central and peripheral
circadian rhythms, which is a fundamental mechanism contributing to the adverse cardiometabolic risk of
sleep loss. We therefore hypothesize that preventing both light exposure and food intake from occurring during
the circadian biological night will prevent internal circadian misalignment during sleep loss, and thereby
mitigate the adverse cardiometabolic risk of short sleep duration. To test this hypothesis, we will conduct a
randomized cross-over laboratory trial to systematically examine the mechanistic contributions of delayed
timing of light exposure and food intake to (1) internal circadian misalignment, (2) impaired insulin sensitivity,
and (3) excess energy intake during experimental sleep loss. We expect our findings will advance the field by
providing valuable insights into physiological mechanisms that mediate risk of obesity and T2D among people
with insufficient sleep. Such knowledge will create the foundation to design novel interventions focused on
optimizing the timing of light and food intake to improve cardiometabolic health in people with insufficient
sleep. These interventions may be especially beneficial in scenarios where sleep loss is unavoidable, ultimately
helping to improve health and quality of life among people with insufficient sleep.

Public health relevance
PROJECT NARRATIVE Chronic insufficient is epidemic in modern society and is a risk factor for obesity and diabetes, representing a significant public health issue. The goal of this project is to examine the mechanistic contribution of internal circadian misalignment to the adverse cardiometabolic risk of insufficient sleep. We expect our findings will create new knowledge that informs the design of novel interventions focused on the timing of light and food intake, with the goal of improving cardiometabolic health in people with insufficient sleep, even when sleep loss may be unavoidable such as in first-responders and medical and military personnel.